Novel Dual-Modality Treatment of Breast Cancer-Induced Osteolysis

Project Summary
Bone is one of the top sites for breast cancer metastasis, and cancer-induced bone loss puts patients at high
risk of painful or even fatal fractures. Exercise with proven benefits of promoting bone and reducing cancer
recurrence is commonly prescribed. However, exercise is challenging for many cancer patients due to treatment-
induced fatigue and fear of activity-related fractures. Moreover, postmenopausal breast cancer patients exhibit
reduced response to exercise due to aging, estrogen deficiency, and chemotherapy-induced apoptosis of
osteocytes, the primary mechanosensing cells in bone. Thus, targeted delivery of chemotherapy to primary and
metastatic tumors while increasing bone’s response to exercise is both desirable and necessary to treat breast
cancer bone metastasis. Whole body vibration is an exercise alternative that generates high-frequency low-
magnitude mechanical signals that stimulate the musculoskeletal system. Pilot data from Dr. Liyun Wang (Project
Co-Lead) demonstrated that whole body vibration augmented with Yoda1, a highly selective activator of Piezo1
ion channels, promoted significant periosteal bone formation in aged mice with and without triple-negative breast
cancer (TNBC) tumors, leading to enhanced skeletal integrity and delayed bone destruction by tumors. Due to
the invasiveness of the tumors, the skeletal protective effects diminished as tumor growth accelerated. To
combat tumor progression, Dr. Emily Day (Project Co-Lead) has developed drug-loaded polymer nanoparticles
(NPs) that are wrapped with plasma membranes derived from TNBC cells. These membrane-wrapped
nanoparticles (MWNPs) were shown to selectively bind to and kill TNBC cells in vivo due to the unique proteins
expressed on the cancer cell membrane surfaces. Together, we propose to test a novel combination therapy
that targets bone’s mechanosensitivity via Piezo1 activation and suppresses tumor growth via MWNPs carrying
the chemotherapy drug doxorubicin (DOX). Our hypothesis is that Yoda1-augmented whole-body vibration could
promote periosteal bone formation in ovariectomized mice bearing metastatic breast cancers, while DOX-loaded
MWNPs would simultaneously suppress metastatic tumors in bone marrow and minimize off-target bone
damage, resulting in health benefits with reduced tumor burden and increased skeletal integrity. In this one-year
supplement, we will investigate the treatment effects of DOX-loaded MWNPs and Yoda1-augmented whole-body
vibration, alone or combined, on tumor growth (Aim 1) as well as on the integrity of bone (Aim 2). Successful
completion of the project will prove the concept of developing safe therapeutic exercise alternatives combined
with anti-cancer treatment with high selectivity and reduced off-target toxicity for metastatic breast cancer
patients. This application addresses a significant health threat to women (breast cancer induced fractures), aligns
with the overall musculoskeletal focus of the parent COBRE grant, and will lead to submission of a NIH R01 or
DoD proposal for in-depth studies of the novel multimodal cancer treatment.

Public health relevance
Project Narrative Bone is one of the top sites for breast cancer metastasis, and cancer-induced bone loss puts patients at high risk of painful or even fatal fractures. Building upon rigorous literature and preliminary data, we will test a novel combination therapy that mitigates cancer-induced osteolysis by stimulating bone growth via activation of Piezo1 mechanosensitive channels in bone cells and suppresses tumor growth via targeted delivery of chemotherapy to metastatic lesions with nanoparticle carriers. This application addresses a significant health threat (breast cancer induced fractures) for women with metastatic breast cancer, which aligns with the overall musculoskeletal focus of the parent COBRE grant and will lead to submission of a follow-on proposal for in-depth studies of the novel multimodal treatment of breast cancer bone metastasis.